Human CRISPRa Cardiac Reprogramming: Model Characterization and Epigenetic Mechanisms

PROJECT SUMMARY / ABSTRACT
The preponderance of morbidity and mortality from cardiac disease results from ischemic damage to the
myocardium. Because of the limited regenerative capacity of cardiomyocytes, ischemic damage results in
permanent myocardial death followed by fibrosis and scar formation. Cardiac reprogramming is a promising new
regenerative approach that has the potential to restore myocardium by converting resident fibroblasts into
cardiomyocyte-like cells. In the decade of research that has followed the first report of cardiac reprogramming,
the field has made significant strides in improving the efficiency of its methods and in understanding the signaling
pathways, transcriptomic changes, and chromatin remodelers that are important for cardiac reprogramming. Our
long-term goal is to help catalyze the application of cardiac reprogramming to human health by improving our
techniques and by deepening our knowledge of the reprogramming process. A constant in cardiac
reprogramming methods has been induction of reprogramming through forced expression of exogenous
transcription factors, usually encoded by a retroviral vector. We have developed a new model of human cardiac
reprogramming that uses CRISPR-based gene activation (CRISPRa) to promote MEF2C, GATA4, and TBX5
expression, and by comparing this model to our current methods, we can gain new insights into the basic biology
of the reprogramming process. Aim 1 is to characterize the molecular, phenotypic, and functional features of our
CRISPRa model. Sarcomeric structure and gap junction patterns will be assayed by immunofluorescence, and
transcriptomic changes will be studied using RNA-seq. Calcium flux through a fluorescent reporter as well as
observations of cell contraction will be measured as functional outcomes. Aim 2 is to study the epigenetic
changes and mechanisms of reprogramming induced by CRISPRa. The epigenetic dynamics at MEF2C,
GATA4, and TBX5 and other genes will be studied, and the epigenomic remodeling unique to CRISPRa
reprogramming will be determined through ChIP-seq and ATAC-seq. The potential mechanisms that lead to
unique epigenetic features will be explored through RNAi as well as conventional CRISPR editing. Overall, this
study will provide key insights into a novel form of cardiac reprogramming, insights that will deepen our
perspectives on cell identity, cell plasticity, and cell fate determination. Furthermore, by developing a CRISPRa-
based model, we have opened a potential avenue for trial of cardiac reprogramming in humans. With further
study, cardiac reprogramming can become safe and effective enough for human regenerative purposes. I will
complete this work under the advisement of Dr. Li Qian, a world-renowned scientist with a passion for
mentorship. My institution has ample resources for the work I have planned, and it offers many opportunities for
learning and professional growth as detailed in my training plan. Upon completing this fellowship, I will be ready
for the next phase of training in my path to becoming an independently funded physician scientist.

Public health relevance
PROJECT NARRATIVE Ischemic myocardial diseases exact a heavy toll on human health, and our ability to treat them is limited in key part by our inability to replace scarred, fibrotic myocardium with new muscle. Through the proposed research, I will develop a new model of cardiac reprogramming based on CRISPR-mediated gene activation. This model will help us learn more about the molecular mechanisms of reprogramming, and it will lay the groundwork for therapeutic use of CRISPR-activation to turn human fibroblasts into cardiomyocytes – in both of these regards, my work will help bring cardiac reprogramming closer to its goal of regenerating hearts and helping patients.